Genetic Basis of Dorso-Ventral Patterning in the Drosophila Eye

In multi-cellular organisms, axial patterning is required for transition of a mono-layered epithelium of an
organ primordium to a three-dimensional organ by delineation of antero-posterior (AP), dorso-ventral
(DV), and proximo-distal (PD) axis. We use Drosophila melanogaster (fruit fly) eye model to study the
highly conserved fundamental process of (axial) DV patterning and growth. During eye development, DV
patterning precedes AP and PD axis patterning, and forms dorsal and ventral compartments. Discerning
the mechanism of axes determination (DV) is crucial for our understanding of organogenesis as the
problems with DV delineation results in developmental/ birth defects in flies to humans. Our long term
goal is to understand the genetic basis of DV patterning which is established by interactions of the dorsal
selector genes and the ventral genes. The Drosophila eye begins from a ventral equivalent state on
which the dorsal fate is established by onset of expression of GATA-family transcription factor Pannier
(Pnr), the secreted morphogen Wingless (Wg), and Iroquois (Iro-C) family proteins. In the dorsal eye, pnr
is not the sole regulator of Wg expression. It strongly suggests that there may be other dorsal eye genes
that are yet to be identified. We have identified a new dorsal eye selector defective proventriculus (dve),
a transcription factor, which acts upstream of wg. To understand the molecular genetic basis of DV
patterning, we will analyze the (1) Investigate wg regulation in the dorsal eye. (2) How Wg
gradient from dorsal eye is interpreted for eye versus head fate? (3) Test if Hippo signaling co-
regulate Wg signaling with DV patterning genes in the eye. Given that the genetic machinery is
conserved, we will also test the role of SATB1, a human ortholog of dve in the eye. Our study will have
significant bearing on (i) developmental mechanisms of lineage restriction and patterning that follow DV
patterning during organogenesis, (ii) role of growth regulatory gene in patterning and (iii) the
understanding of etiology of early childhood retinal diseases. (iv) How do independent pathways interact
to regulate growth and patterning in the developing eye? The proposed studies will generate insights into
(1) how dorsal eye genes interact to determine eye versus head fate by regulating Wg signaling, (2) How
two independent pathways like Hippo signaling and DV patterning coregulate Wg signaling to promote
growth and patterning in the developing eye? (3) SATB1 is mainly known to regulate growth and our
studies in eye will provide insight into growth regulation and patterning function of SATB1. These studies
will have significant bearings on understanding the genetic mechanism of early developmental events
during organogenesis in higher vertebrates. The knowledge generated from these studies is expected to
elucidate fundamental mechanisms in patterning and growth of normal visual function and within the
context of retinal disease and birth defects in the eye.

Public health relevance
This proposal utilizes Drosophila (fruit fly) eye model to study the genetic mechanism of axial patterning (Dorso-ventral, DV patterning) and growth, a critical and a fundamental process required for the transition of a single layer of cells into a three-dimensional organ. Given the conservation of genetic machinery (genes) required for these fundamental processes, we propose to study the (i) molecular genetic function of DV patterning genes in patterning and growth (ii) and interactions of these DV genes with evolutionarily conserved growth regulatory Hippo signaling pathway with emphasis on discerning crosstalk between two core pathways that are known to act independently in regulating Wingless signaling and thereby determining positional fate and regulate growth during organogenesis. These studies will have significant bearing on understanding the genetic basis of organogenesis, cause of abnormal processes that lead to visual system birth defects, retinal defects, and therefore is of immediate relevance and importance to human health.